Development of a model of Gonococcal conjunctivitis for vaccine evaluations

Abstract
The serious concerns of the health-care community around the current state of worldwide N. gonorrhoeae infec-
tions are well known and documented in the infectious diseases, microbiology and immunology communities
and literature. The major manifestations of gonococcal (GC) infection worldwide are genital tract infections and
conjunctivitis, the latter a major problem in infants born in low and middle income countries, diagnosed as oph-
thalmia neonatorum. There is a global concern about effective treatments due to antimicrobial resistance and
the threat of pan-resistant, untreatable GC infections is high. Thus, new approaches, strategies and tools are
needed to address the consequences from this exceedingly successful human pathogen. At the top of this list
are vaccines and immunotherapeutics to control GC infection and transmission. Yet, unlike its cousin, N. men-
ingitides, where vaccine-preventable disease has been obtained by targeting the immunogenic, serologically
variable capsular polysaccharides or, more recently, surface proteins for serogroup B, such vaccine targets have
not been identified on N. gonorrhoeae cells. Indeed, there are no known correlates of human immunity mediating
resistance to GC infection. Furthermore, reinfection with N. gonorrhoeae seems to occur sufficiently frequently
to suggest that vaccine antigens are either serologically variable and differ markedly among strains, or, infection
with GC simply does not engender sufficient protective immune responses.
The goal of this research project is to develop and validate a murine model of N. gonorrhoeae conjunctivitis in
both adult and neonatal mice to study virulence and immunity to this pathogen in a readily accessible laboratory
animal model. A second goal will be to evaluate the prophylactic and therapeutic potential of antibody therapeu-
tics to N. gonorrhoeae to substantiate the utility of the conjunctival infection model for such studies. These targets
include the conserved bacterial surface polysaccharide poly-N-acetyl glucosamine (PNAG) that we have shown
surrounds the outer surface of N. gonorrhoeae and serves as a target for bactericidal antibody, and the surface
lipooligosaccharide (LOS) recognized by monoclonal antibody (MAb) 2C7.
We propose to take advantage of our extensive experience with murine models of ocular infections to study N.
gonorrhoeae conjunctivitis in adult and neonatal mice. We will determine the growth and dose parameters
needed to establish infection in both of these murine settings, the latter as a model for ophthalmia neonatorum.
We will evaluate pathogenesis of multiple N. gonorrhoeae strains, test active and passive immunotherapies for
impacting bacterial burdens and conjunctival pathology, and determine some of the in vitro and in vivo immune
effectors needed to impact these measures of infection and disease. Success would open up the potential to
readily study additional vaccines and therapies, as well as virulence factors and host innate and acquired im-
munity to N. gonorrhoeae in a clinically-relevant setting. Thus, an in vivo murine model for GC conjunctival
infection would fill in the gaps currently limiting the study of virulence and immunity to N. gonorrhoeae infections.

Public health relevance
Worldwide infections with the bacterium Neisseria gonorrhoeae are a major problem, and increasing antibiotic resistance in this organism necessitates developing new approaches for prevention and treatment. The major manifestations of gonococcal infection worldwide are genital tract infections and conjunctivitis in the eye, the latter a major problem in infants born in low and middle income countries, manifest as ophthalmia neonatorum. This project will develop a mouse model to study N. gonorrhoeae conjunctivitis in adult and neonatal mice to evaluate vaccine candidates and mechanisms whereby they induce antibodies that can protect against infec- tion in the eye.